High throughput genotyping &genotype cells for single nucleotide polymorphisms

High throughput genotyping of SNPs promises to revolutionize our understanding of genetic variation and the ability to relate genetic variation to phenotypic variation, including disease for 3 reasons: (1) the number of SNPs which are potentially available -more than 300,000 across the human genome; (2)SNPs represent the majority of sequence variants which alter the structure and expression of gene products; (3) these variants are amenable to analysis by automated methods. We have implemented high throughput genotyping of SNPs using TaqMan type primer/probe methodology in which each allele in a biallelic polymorphism generates a different fluorescent signal which can be quantitated immediately following PCR [on an end-point multiwell fluorescent detector - the Cytofluor 4000] or even during PCR [using the PE 7700 which permits quantitation during each PCR cycle]. A critical issue is the ability to develop algorithms for automated allele calling. Using a set of readily genotyped and more problematically genotyped SNPs, we have made an advance over the available technology for automated genotype calling. We have used a K- means clustering algorithm that evaluates the ratio of the two fluuorescent allele signals to make accurate genotype calls on data that would have needed manual evaluation. - automated genotyping, single nucleotide polymorphisms